Effect of Cannabis Use on Alcohol Craving and Consumption among those in Alcohol Treatment

PROJECT SUMMARY/ABSTRACT
Among those with AUD, cannabis is the most commonly used psychoactive substance. Although initial
evidence suggests an overall detrimental impact of cannabis use (CU) on longitudinal AUD treatment
outcomes, there is significant divergence about how CU impacts alcohol consumption and craving. Competing
theories about the association between CU and alcohol focus on whether CU acts as a substitute (i.e.,
replacing the effects of alcohol, resulting in decreased craving, use, and harms) or complement (i.e.,
enhancing the effects of alcohol, resulting in increased craving, use, and harms). Preliminary work in non-
treatment engaged samples suggests important mechanisms (e.g., craving) and moderators (e.g., frequency of
CU, history of simultaneous use, trait impulsivity) may elucidate these competing theories. An important gap in
the literature is in the examination of prospective and momentary effects of naturalistic CU on alcohol craving
and consumption among individuals in alcohol treatment. The proposed study aims to address this gap using
an intensive longitudinal design to comprehensively examine within- and between-person patterns of CU on
alcohol outcomes over the critical first year after treatment initiation. Key outcomes among those early in
treatment are alcohol craving and risky alcohol consumption patterns (rate of consumption and volume
consumed). Use of alcohol biosensors allow for the objective measurement of these alcohol consumption
patterns as they naturally occur. The proposed project will be the most comprehensive examination to date of
the impact of CU on alcohol treatment outcomes and the first to examine these associations in the natural
environment using the BACtrack Skyn to passively mesure transdermal alcohol concentration (TAC). Alcohol
craving will be measured as an important outcome of CU in the moment, as well as a mechanism by which CU
leads to alcohol consumption. A longitudinal ecological momentary assessment (EMA) burst design (four 10-
day bursts at baseline, 1, 2, and 3 months) will be used to isolate the momentary impact of CU on alcohol
craving and consumption (measured via TAC) in a stratified sample of recent cannabis users. Following this
EMA phase, participants will engage in 6, 9, and 12 month follow-ups to fully capture CU and alcohol
patterns/AUD remission over the first year after treatment initiation. This research will directly inform: a) clinical
decision-making about the risks of CU during alcohol treatment, b) future intervention development for AUD,
and c) policy in the wake of expanding cannabis legalization; and is well-aligned with the objectives of the
Collaborative Research on Addiction at NIH.

Public health relevance
PROJECT NARRATIVE Cannabis is the most commonly used psychoactive substance among those with Alcohol Use Disorder (AUD), yet there is a lack of data examining the direct impact of cannabis use on alcohol-related treatment outcomes. This project will use ecological momentary assessment and transdermal alcohol biosensors to study the momentary impact of cannabis use on alcohol craving and consumption in the natural environment among those early in AUD treatment. Results from this research will have direct impact on cannabis messaging, clinical decision-making, and intervention development for those with AUD.